In Situ Force Mapping to See Mechanical Communication in Action in Genomes of Living Cells

Project Summary/Abstract
Forces are “bits” of mechanical information that cells are thought to use to rapidly (>10 µm/sec) distribute
regulatory signals or orchestrate transitions between different functional architectures. Dysregulation of
mechanical communication in various subcellular structures is associated with disease including fibrotic
disorders, cancers, and cardiovascular pathology, and as such represents a critical target for an emerging
class of molecular mechanotherapies. However, our knowledge of whether and how cells process internally
and externally generated mechanical cues is still in its infancy. In large part, this is because the current
technology has a very limited ability to visualize and quantify intracellular forces originating from ~50-nm
sources and spreading micron-scale distances, the information that is critical for understanding the mechanics
of large subcellular structures such as the genome and cytoskeleton. To address this challenge, my lab is
developing two force nanoprobes that can be delivered to the cell to form a stress-sensitive meshwork
capable of reporting forces acting over 18-75-nm range (the size of the probes) and distributed in time and
space, thus providing a map of intracellular forces in their normal context. (1) The first nanoprobe provides a
direct quantitative measure of force by converting applied mechanical stress to photons, i.e. producing
mechanoluminescence. Since no photoexcitation is needed, autofluorescence background and phototoxicity
are avoided, providing an unprecedented level of sensitivity, which is unachievable in photoluminescence-
based techniques. In this approach, we exploit our recent discovery of the nanoscale mechanism for elastic,
repeatable mechanoluminescence in ZnMnS. Force nanoprobes will be based on ZnMnS nanorods with
stacking faults, a structural defect, which our research identified as vital for mechanoluminescence. (2) The
second nanoprobe is based on dynamic DNA nanostructures, which report applied force by switching
between open and closed states with different colors of photoexcited luminescence, i.e. produce a binary
readout. The readout is based on the base pairing of a 20-bp DNA sequence that allows for sensitivity in the
sub-pN range. Thus, this nanoprobe can register mechanically induced changes in its immediate environment
on the scale just above the thermal bath. Finally, we will integrate our force nanoprobes with super-resolution
imaging capabilities existing in the lab to create a map of intracellular forces generated by the genome of
living HeLa cells. This rich experimental setup will empower us to answer a range of open questions in the
field of genome mechanobiology, with the long-term goal to resolve the principles underlying mechanical
communication in the 3D genome. Overall, the proposed research program will provide a quantitative method
for studying mechanical – and not biochemical – signaling in large subcellular structures in physiological
environments. The proposed tools can be translated to clinical samples and thus have the potential to inspire
categorically new therapies for diseases associated with pathological mechanotransduction.

Public health relevance
Project Narrative The proposal aims to develop force nanoprobes for measuring forces in living cells with the goal to elucidate how highly heterogeneous 3D organization of the genome promotes and censors the generation, accumulation, and redistribution of forces. If successful, the proposed technology has the potential to inspire categorically new mechanotherapies for diseases associated with pathological mechanotransduction in the genome, including cancers and cardiovascular pathology. This versatile tool can be adapted by other researchers to study various pathways of mechanical signaling in cells, both in basic research and clinical practice.